Novel Mechanisms of Oxidative Stress Response in Heart Failure

Novel Mechanisms of Oxidative Stress Response in Heart Failure
A large volume of literature indicates an association of oxidative stress with end stage heart failure. Myocardial
ischemia or infarction is the most common cause of heart failure, which is difficult to treat and costly to manage,
and has a high mortality rate. A deficiency in oxidant removal or damage repair systems in the myocardium may
explain the progression of heart failure. At the cellular level, low to mild levels of oxidative stress activate Nrf2
transcription factor to turn on the expression of antioxidant and detoxification genes. We have found that de
novo Nrf2 protein translation serves as an important mechanism for Nrf2 activation under oxidative stress. How
certain proteins, such as Nrf2, can be selectively translated when cardiac cells encounter oxidative stress
remains largely unknown. When investigating the ribosomes using quantitative LC-MS/MS based proteomics,
we have recently discovered that YTHD2, a YTH domain containing N6 methyladenosine (m6A) binding protein,
increased its association with the ribosomes during oxidative stress. We have found that YTHD2 increases the
binding to Nrf2 mRNA and have detected an increase of m6A in Nrf2 mRNA with oxidative stress. Knocking out
YTHD2 blocked oxidants from inducing Nrf2 protein. These data lead us to hypothesize that YTHD2 reading of
m6A in the Nrf2 5’ untranslated region (5’UTR) serves as a passport for de novo Nrf2 protein translation
under oxidative stress. The loss of Nrf2 protein translation mechanisms may contribute to end stage
heart failure. Aim 1 will test that oxidative stress causes Nrf2 mRNA methylation at specific sites and m6A
landscape change due to activation of METTL3 methylase. Aim 2 will test whether YTHD2 binding causes a
Nrf2 5’UTR conformation change and recruitment of a translation initiation complex for de novo Nrf2 protein
translation. Aim 3 will demonstrate the losses of stress induced protein translation machinery, regulated mRNA
methylation, and Nrf2 mediated cytoprotection in end stage heart failure patients. Our study will advance the
knowledge pertaining to a novel discovery involving RNA methylation for de novo protein translation in oxidative
stress response. This project will utilize transcriptomic data from heart failure patients to validate mechanistic
findings from laboratory research for implications in real life human disease.

Public health relevance
Narrative: This project will investigate RNA methylation for Nrf2 protein translation by oxidative stress in cardiomyocytes and the loss of Nrf2 mediated protection in the end stage heart failure.